SULFATED POLYSACCHARIDES AS ELASTASE INHIBITORS IN CYSTIC FIBROSIS

This protocol will evaluate the hypothesis that the elastolytic activity of bronchial secretions in cystic fibrosis can be decreased by treatment with aerosolized dextran sulfate(DS), a sulfated polysaccharide protease inhibitor.